Delineating phosphorylation-mediated regulation of mitochondrial function

Abstract
Mitochondria are complex organelles found in virtually all eukaryotic cells. These organelles orchestrate diverse
functions such as energy expenditure, nutrient selection, and ion homeostasis, and do so through the
coordination of over 1,000 mitochondria-resident proteins. Most of these mitochondrial proteins are
phosphorylated under select physiological conditions, but surprisingly little has been done to characterize these
organellar modifications. Motivated by the observation that mitochondria house numerous protein phosphatases,
we predicted that regulated protein phosphorylation may play a larger role in organellar homeostasis than is
currently appreciated. Indeed, our studies show that the knockout of one mitochondrial phosphatase, Pptc7,
leads to stark metabolic dysfunction culminating in fully penetrant perinatal lethality in mice. This surprisingly
severe pathophysiology indicates that proper management of protein phosphorylation is requisite for
mitochondrial homeostasis. Despite these data, it remains unclear how mitochondrial proteins become
phosphorylated and the extent to which individual phosphorylation events contribute to mitochondrial function.
We will begin to address these gaps in knowledge by mapping the full breadth of substrates of matrix-localized
kinases and by testing the cellular compartment in which mitochondrial-destined proteins become
phosphorylated. These studies will begin to address longstanding questions as to the mechanisms enabling
mitochondrial protein phosphorylation as well as and the genetic identities of its regulators. To complement this
work, we will utilize mechanistic, hypothesis-driven approaches to test the effects of phosphorylation on two
proteins, Timm50 and Idh2. These two proteins are reproducibly hyperphosphorylated in Pptc7 KO conditions,
suggesting they drive at least a subset of the stark phenotypes associated with the knockout of this phosphatase.
Furthermore, these two proteins play key roles in mitochondrial protein import and TCA cycle-mediated
metabolism and their regulation would likely have broad influence on mitochondrial function. We will test the
effects of Timm50 and Idh2 phosphorylation at the biochemical level (determining how this modification affects
protein functions), at the cellular level (determining how modulation of these phosphorylation events affect
organellar processes such as protein import and metabolic flux), and at the organismal level (testing how
phosphorylation of these proteins may mediate pathophysiology – particularly of phenotypes manifested in Pptc7
KO mice). Collectively, this work will link kinases to mitochondrial function and will establish a workflow to
delineate the functions of individual phosphorylation events from the biochemical to the physiological level. As
kinases are druggable and have had positive clinical impact in human disease, these studies may uncover novel
therapeutic targets through which we can resolve mitochondrial dysfunction found across human pathologies.

Public health relevance
Project narrative Mitochondria, commonly known as the “powerhouses of the cell,” facilitate much of the energy production in cells, but how they respond to dynamic cellular cues is not fully understood. This proposal will test the hypothesis that phosphorylation constitutes an important regulatory mechanism in mitochondria. As kinases, the mediators of phosphorylation, are clinically relevant therapeutic targets, this project may reveal new pharmacological strategies to address mitochondrial dysfunction in human disease.